Illuminating Dark Kinase Activity in HNSCC, LUSC, and LUAD through Integrative Kinase Proximity and Phosphoproteomics Analysis

PROJECT SUMMARY
Kinases are highly druggable targets for cancer therapy. In recent years, large clinical
phosphoproteomics datasets have expanded our understanding of how the phosphoproteome is altered in
several cancer types. However, annotation of the phosphoproteome is significantly lacking, which presents a
significant obstacle for translating clinical phosphoproteomic data into therapeutic leads. Because of poor kinase-
substrate annotation, inference of kinase activity from phosphoproteomic data relies either on in vitro data or on
databases of phosphorylation signatures from cells treated with low-specificity kinase inhibitors, both of which
have substantial disadvantages. In vitro kinase assays don't capture kinase specificity governed by localization
or protein interactions in the cellular context, and molecular signatures often lack the ability to discriminate
between downstream phosphorylation sites and those that are direct substrates of a kinase. My long-term goal
is to aid efforts to understand phosphoproteomic re-wiring in cancer by developing experimental and
computational methods to define kinase-substrate relationships in an unbiased and high throughput manner.
The human genome encodes ~650 kinases, of which many remain poorly studied. The NIH Illuminating the
Druggable Genome (IDG) consortium has defined 162 of these as under-researched `dark' kinases due to a lack
of publications, patents and small molecule inhibitors for them. As part of this initiative, our lab has collected
proximity proteomics data for 101 dark kinases. My ongoing work focuses on leveraging probabilistic scoring
and integrative data analysis using a variety of public data to assign functional roles for these kinases. The main
objective of this proposal is to leverage this data by integrating it with gain-of-function (GOF) phosphoproteomics
assays and clinical phosphoproteomics data. When combined proximity data, GOF phosphoproteomics data
enables the identification of high-confidence substrates of the kinase, which can be used to infer changes in
kinase activities in cancer patients. I hypothesize that data from these assays will reveal novel biological insights
in clinical tumor phosphoproteomic data, and enhance our understanding of the role of protein phosphorylation
in cancer. In this proposal, I outline plans to integrate our kinase proximity data with public CPTAC data and
identify high-confidence substrates for 10 kinases with implicated roles in mechanisms of tumor progression in
lung and upper airway cancers. This work will help me develop skills in cancer informatics, phosphoproteomics,
proximity proteomics and multi-omic data integration. By translating my studies of dark kinases towards clinically
tractable cancer research, this training will empower me to progress my career studying the cancer
phosphoproteome.

Public health relevance
PROJECT NARRATIVE Kinases are highly druggable targets for cancer therapy, but a large subset remain under-researched. By integrating data proximity labelling experiments and with data from kinase gain-of-function-phosphoproteomics assays, I identify substrates and biological roles of under-researched kinases. In this project I will leverage kinase proximity data, public tumor proteogenomic data, and phosphoproteomics assays to better understand kinase activity in lung and head and neck cancer and identify kinases with high therapeutic potential.